Evaluating Healthy Families PrEP: an intervention to promote PrEP use during periconception, pregnancy, and postpartum periods for women in rural Uganda

ABSTRACT
Periconception, pregnant, and postpartum women in HIV-endemic settings are at high risk for acquiring
HIV. In Uganda, both fertility rates (4.7 children/woman) and HIV prevalence (8%) are high, and many women
conceive with partners with HIV who are not virally suppressed. Oral tenofovir-based PrEP is a highly effective
strategy for reducing HIV-acquisition and approved for use during pregnancy and breastfeeding.
We designed and pilot tested the 3-session Healthy Families-PrEP intervention in a Ugandan HIV care
clinic. Women planning pregnancy were counseled on how to conceive while avoiding HIV acquisition; offered
PrEP; and, for those choosing PrEP, provided with quarterly adherence support. Of 131 women enrolled, 90%
initiated PrEP and 85% of those initiating PrEP took at least 80% of doses (electronic pill cap) over 9 months;
54% had whole blood tenofovir metabolites consistent with protective dosing at 6 months, and thus 43% of all
enrolled used effective PrEP at 6 months. For women with pregnancy, adherence persisted over 9 months.
Given compelling pilot data and the importance of HIV prevention for perinatal women, we propose to adapt
and test this promising intervention to reduce HIV incidence among periconception, pregnant, and postpartum
women accessing community care in Uganda. In Aim 1, qualitative focus group discussions with women,
interviews with key stakeholders, and clinic observations guided by the Consolidated Framework for
Implementation Research and our client-level conceptual framework will inform adaptation of the intervention to
community clinics and postpartum women. We then propose a cluster-randomized control trial with N=10 health
centers to evaluate effectiveness (Aim 2) by enrolling N=600 women planning for pregnancy from intervention
and control clinics (1:1). Women will be followed for at least 6 months; those who become pregnant will remain
enrolled through 18 months to allow for postpartum follow-up. The primary effectiveness outcome will be
proportion of women with whole blood PrEP metabolites (TFV-DP) consistent with taking at least 4 weekly doses
at 6 months. Tenofovir concentrations in whole blood and plasma (quarterly), questionnaires, and in-depth
interviews will provide data to understand factors associated with PrEP use among peripartum women in the
community setting. In Aim 3, we will determine the incremental cost-per-person participating in Healthy Families-
PrEP and estimate the cost-effectiveness per incident HIV infection averted and per life-year saved among
enrolled women and their infants.
Adapting this intervention to community clinics and testing effectiveness addresses NIH Office of AIDS
Research priorities to reduce HIV incidence and implement research discoveries for public health impact.
Moreover, the work aligns with global and Ugandan Ministry of Health goals to reduce HIV incidence among
women of reproductive age and eliminate perinatal transmission.

Public health relevance
Project Narrative Women in Uganda who are planning for pregnancy, pregnant, or postpartum and have a partner living with HIV are vulnerable to acquiring HIV. We developed a counseling intervention that supports women to make comprehensive safer conception plans and most chose to use and were able to adhere to daily oral PrEP during periconception and pregnancy. We now propose to adapt the intervention to community clinics and postpartum women and test the intervention; the goal is to reduce HIV incidence among women and children.